Developing SWIR fluorophores for enhanced visualization of buried nerves in head and neck cancer surgery

PROJECT SUMMARY
Iatrogenic nerve injury represents one of the most feared surgical complications and remains a major cause of
morbidity across all surgical specialties. Head and neck cancer surgery is a compelling clinical example of sig-
nificant patient morbidity, where nerve damage provoked by surgical trauma is reported in up to 30% of patients,
resulting in severe pain and increased stress exceeding that seen in many other cancer types due to the potential
disfigurement. Surprisingly, no clinically approved technology currently exists to enhance intraoperative nerve
identification, where techniques for nerve visualization still rely heavily on neuroanatomical knowledge and tra-
ditional white light visualization. Fluorescence Guided Surgery (FGS) has made significant advances using FDA-
approved near-infrared (NIR, 650-900 nm) fluorophores and cancer-targeted probes. However, clinical nerve
FGS lags behind in the development and translation of cancer-specific contrast agents due to challenges in
creating clinically relevant nerve-specific fluorophores. Importantly, although NIR fluorophores offer better tissue
penetration and reduced light scattering compared to the visible spectrum, their utility is still limited in imaging
depths and resolution for buried fine tissue structures (e.g., facial nerves, cranial nerves). Given the varied sizes
and depths at which facial nerves are buried, and the critical need to minimize nerve damage, there is a com-
pelling case for exploring beyond the NIR spectrum. The short-wave infrared (SWIR, 900–1700 nm) region
emerges as a superior alternative for in vivo fluorescence imaging, with advantages including further reduced
light scattering and increased tissue penetration, leading to dramatically improved resolution. These properties
are particularly advantageous for the visualization and identification of delicate facial nerve tissues during head
and neck cancer surgeries, where precise identification at depth can significantly mitigate the risk of iatrogenic
nerve injury. However, the development of a SWIR nerve-specific small molecule has been a significant chal-
lenge, because these fluorophores need to have a low enough molecular weight to cross the tight blood-nerve
barrier junction, with a sufficient degree of conjugation for SWIR excitation and emission, inherently increasing
their molecular weight. Our preliminary work has led to the development of over 400 novel oxazine-based small
molecule fluorophores, providing quantitative structure-activity relationship (QSAR) modeling on the oxazine
scaffold for nerve specificity management. Building on this foundation, we propose to synthetically develop first-
in-class SWIR nerve-specific fluorophores that will push the boundaries of current imaging capabilities. The
newly designed SWIR fluorophores will undergo rigorous validation for nerve specificity in rodent models, and
the most promising candidates will be validated for their efficacy in buried facial nerve visualization during head
and neck cancer surgeries in more complex cancer models. This work is poised to set a new standard for nerve
preservation in one of the most challenging areas of oncologic surgery.

Public health relevance
PROJECT NARRATIVE Positive margins are reported in up to 30% of head and neck cancer surgeries, with margin status being a major prognostic factor for overall survival. While the primary goal of surgical treatment is complete cancer removal, preserving the function of nearby nerve tissue is equally important to prevent significant morbidity. Herein, we propose to develop novel short-wave infrared nerve-specific fluorophores to enhance nerve visualization and improve surgical outcomes for head and neck cancer patients.